PITUITARY HYPOTHALAMIC DISEASE

The objectives of these studies were to determine hormonal and psychological correlations of the anatomic features of pituitary and hypothalamic tumors and other diseases.